Tumor Immunology and Immunotherapy (TII)

TUMOR IMMUNOLOGY AND IMMUNOTHERAPY (TII) RESEARCH PROGRAM
ABSTRACT
The UCLA Jonsson Comprehensive Cancer Center (JCCC) Tumor Immunology and Immunotherapy (TII)
Research Program has two primary goals. The first is to enhance understanding of tumor immunology and the
tumor microenvironment, and their responses to different modalities of cancer immunotherapy. The second is to
develop novel immune-based clinical therapies for patients with cancer to favorably impact the Los Angeles
County (LAC) catchment area communities served by the JCCC and beyond. The TII Program brings basic,
translational, and clinical scientists together in an environment that has spawned novel investigator-initiated
immunotherapy clinical trials for patients with multiple types of cancer. Main areas of established intra- and interprogrammatic
collaborative research include: 1) bringing new cancer immunotherapies to drug regulatory
approval to improve treatments for patients with cancer; 2) analysis of the mechanistic basis of responses and
resistance to immune checkpoint blockade immunotherapies; 3) clinical trials of genetically engineered T
lymphocytes and their precursors with T cell receptors (TCRs) or chimeric antigen receptors (CARs) to generate
a cancer-directed immune system; 4) non-invasive imaging of tumor antigen-specific T cell distribution and tumor
targeting in vivo; 5) new platforms for immune monitoring of T cell responses to cancer; 6) the relationship
between inflammation and cancer; 7) the use of antibody fusion proteins for cancer therapy; 8) combinations
with targeted therapies to sensitize cancer cells to immunotherapy; and 9) improving the lives of patients with
AIDS-related malignancies. The basic and translational research within the TII Program uses all JCCC CCSGsupported
infrastructure and Shared Resources in ongoing research efforts. The Flow Cytometry Shared
Resource (FCSR) is a key facility required for most (if not all) research projects within the Program. The Small
Animal Imaging Shared Resource (SAISR) has made possible the pursuit of successful projects in T cell imaging
in vivo, projects that are now being brought from preclinical models to patients. The JCCC/Human Gene Medicine
Program Good Manufacturing Practice (GMP) suite is providing the required physical infrastructure to support
multiple Program investigators in manufacturing cell and gene therapy products in-house, meeting all local, state,
and federal regulatory requirements for human administration. The TII Program has 41 members hailing from 16
departments. As of 3/1/2024, peer-reviewed cancer-related funding for the Program is $10.3M and total funding
is $14.1M. From 2019 – 2023, TII Program members produced 450 publications, of which 20% are intraprogrammatic,
45% are inter-programmatic and 53% are in high impact (IF >10) journals.